Temporal control of cell patterning, signaling, and movement in early embryos

Summary:
Regulation of gene expression along the dorsal-ventral (DV) axis of Drosophila embryos serves as a paradigm
of developmental patterning. Comparative studies of cis-regulatory elements that support expression along the
DV axis from many research groups have made it clear that combinatorial input into enhancers by multiple
transcription factors drives distinct spatial-outputs of gene expression. A pivotal regulator of this patterning
process is the maternally provided transcription factor Dorsal (Dl), homolog of NFκB. Dl functions as a
morphogen to activate target gene expression in a concentration-dependent manner along the DV axis,
contributing to the initiation of zygotic gene expression at the maternal-to-zygotic transition (MZT). Using live
imaging, we quantified the Dl gradient in embryos and found, surprisingly, that levels change not only in space
but also build in time. Our focus during the previous funding period was to study the impact of these Dl dynamics
on target gene expression using quantitative approaches involving analysis of live imaging or fixed embryo time-
series data to provide insight. In the current proposal, we follow three new and exciting directions, which relate
to the timing of cell actions in early embryos and arose as a result of the previous work. Project 1 involves
studying how broadly expressed activators and repressors cooperate to control the onset of zygotic gene
expression during the MZT. We hypothesize that broadly expressed repressors are equally important to pioneer
activators in the control of chromatin accessibility and thereby also regulate initiation of zygotic gene expression.
Project 2 focuses on dissecting the function of short transcripts for long genes that are expressed specifically in
the early syncytial embryo. We hypothesize that these short transcripts act to regulate timing of cell signaling
pathway activation by functioning as dominant-negative variants of signaling molecules. Project 3 focuses on
identifying the mechanism by which FGF signaling regulates adherens junctions (AJs) and their interaction with
the actin cytoskeleton to contribute to the first epithelial-to-mesenchymal transition (EMT) in embryos; in
particular, to understand how a degron associated with one FGF ligand, Pyramus, limits signaling time. The
overarching goal of the proposed research program is to understand how the timing of these cell activities -
patterning, signaling, and movement - are controlled in developing Drosophila embryos and to provide general
insights applicable to higher animals. While many studies have focused on spatial outputs of gene expression,
less is known about the temporal dynamics of patterning. Drosophila embryos are a tractable system to study
MZT as it occurs in 3-4 hours, in contrast to taking days in preimplantation mammalian embryos. The Drosophila
embryo is also amenable to live in vivo imaging and tracking analyses making it well-suited to the study of
nascent transcription and cell morphology. Lastly, our proposed studies will provide general insight into early
embryo development of higher animals as many regulatory mechanisms are likely conserved.

Public health relevance
NARRATIVE The overlying goal of the research program is to understand how timing of cell activities - patterning, signaling, and movement - is regulated in the Drosophila early embryo as development proceeds. In particular, the proposed experiments will investigate how initiation of zygotic gene expression is controlled; and how this results in the activation of cell signaling, including through FGFs, which is instrumental for the support of cell movements at gastrulation to transform the blastoderm embryo into multiple layers with distinct tissue types. This work has the potential to provide insight into how diverse cellular functions are coordinated to support normal embryonic development in higher animals, as the regulatory mechanisms are likely conserved.